Core 1: Protein Biochemistry and Enzymology (PBE) Core

ABSTRACT
DNA double-strand breaks (DSB)s are eliminated primarily through two mechanistically distinct pathways,
namely, non-homologous DNA end joining (NHEJ) and homology-directed repair (HDR). Importantly, HDR
also functions to repair damaged DNA replication forks and to protect stressed replication forks against
attrition mediated by cellular nucleases. The selection of HDR versus NHEJ is subject to intricate regulatory
control and is linked to the cell cycle. Most notably, the 53BP1 axis, consisting of the chromatin epigenetic
mark reader 53BP1 and associated factors, including DYNLL1 and the hetero-trimeric CTC1-STN1-TEN1
(CST) complex, functions to restrict HDR in G1 phase of the cell cycle to channel DSBs into NHEJ. Our
Program Project research teams at the University of Texas Health Science Center at San Antonio, Columbia
University, and Dana Farber Cancer Institute focus on delineating the mechanisms that underpin the DNA
end resection and RAD51 presynaptic filament assembly steps of HDR, and how these processes are
negatively regulated by the 53BP1 axis, and the manner in which this restriction is overcome by HDR protein
complexes that harbor the tumor suppressors BRCA1 and BRCA2. The Protein Biochemistry and
Enzymology (PBE) Core is directed by a seasoned nucleic acid biochemist/enzymologist and will help our
Program Project overcome technical bottlenecks and achieve project objectives by (1) providing state-of-
the-art support in protein expression and purification, protein-protein interaction studies, nucleic acid
biochemistry, and also enzymatic assays germane for the research goals being pursued; (2) meeting new
challenges through consultation with investigators on matters pertaining to our areas of expertise; (3)
training students and fellows in various protein biochemistry and enzymological methods and techniques;
and (4) fulfilling the protein production needs of the Structural Biology and Biophysics (SBB) Core.
1

Public health relevance
NARRATIVE Our Program Project focuses on key aspects of a conserved DNA break repair mechanism called homology- directed repair and determining how this process is regulated by 53BP1, its associated factors, and the tumor suppressors BRCA1-BARD1 and BRCA2. The Protein Biochemistry and Enzymology (PBE) Core has overcome technical bottlenecks to be able to provide high quality protein preparations to Program Project investigators to facilitate their foundational studies. The proven expertise of the PBE Core in nucleic acid and DNA repair enzymology will prove to be crucial for the overall productivity, synergy, and success of the Program Project. 1